Intervention Methods: Provision and Connection through Technology (IMPACT)

PROJECT SUMMARY
Interventions designed to improve pediatric health are often stymied by factors such as lengthy research-to-
practice gaps, limited effectiveness, and poor uptake by those they are intended to serve. Newer models of
healthcare, which are transforming “top down” hierarchical systems into models of true partnership among
patients, families, and healthcare providers, offer new opportunities to overcome these challenges. To
accommodate newer models of care and to address the systematic healthcare inequities that have lifelong
consequences for children, the next generation of healthcare researchers must be equipped to conduct
intervention research that reduces disparities, utilizes cutting edge methodological and technological
approaches, and allows for rapid implementation of effective interventions. Strategies that focus on direct
partnership with target populations at all levels of intervention development, delivery, and dissemination hold
great promise to transform pediatric healthcare. Integrating technology at all stages of intervention research is
also a critical and important strategy to mitigate challenges. The proposed Intervention Methodology: Provision
and Connection through Technology (IMPACT) Core has two inter-related components, one dedicated to
intervention development, delivery, and implementation (Intervention Science); the second focused on the
technological expertise and tools needed to create and sustain interventions (Technological Applications). With
this focus, IMPACT will support the development and delivery of user-centered, stakeholder-engaged,
technology-enabled interventions to promote health and well-being for pediatric populations experiencing health
disparities and social inequities. The IMPACT core will provide resources including expertise, tools, training, and
technical assistance to investigators developing and conducting programs of technology-enhanced intervention
research to reduce disparities and improve the health and wellbeing of children and families across Delaware.
The IMPACT Core will accomplish this goal by: (1) creating a robust infrastructure to facilitate the development,
delivery and implementation of scalable, innovative, technology-enhanced interventions primed for delivery to
patients and families impacted by health disparities and social inequities, (2) preparing and supporting
investigators in the conduct of intervention research using technology to address equity in pediatric health care,
and (3) creating procedures and processes to manage and sustain the IMPACT Core. The Core Director, Dr.
Kimberly Canter, will be supported by a team of content experts, an internal advisory committee, and Career
Consultants who will provide mentorship at the mid-career level. The goals of the IMPACT Core directly support
the overall aims of the REACH Center to develop, evaluate, and implement innovative technology-enhanced
interventions and models of care to overcome the complex socio-ecological factors responsible for inadequate
access to health care and child health.